Center of Excellence for High Throughput Proteogenomic Characterization

Project Summary
Cancer proteogenomics encompasses methods that integrate mass spectrometry (MS)-based measurements
of protein abundance and post-translational modifications (PTMs) with genomic, epigenomic, and transcriptomic
data from preclinical cancer models and tumor samples. The multidisciplinary Proteogenomic Characterization
Center we propose will employ a range of state-of-the-art MS-based proteomic and metabolomic technologies
to systematically generate and integrate high quality, comprehensive and quantitative proteomic and
metabolomic data with genomic data. Our overarching goals are to leverage the integrated data to identify
signatures of cancer drivers, detect signaling network adaptations and provide information on PTMs that affect
cellular signaling, molecular complex formation, and protein location, translation and stability in human
biospecimens and relevant models of cancer. Peptidomes of the class I and II human leukocyte antigens (HLA)
of the tumors will also be analyzed to shed light on tumor-immune escape mechanisms and antigen processing
in cancer, improve algorithms for prediction of antigen display and immunogenicity and inform development of
personalized cancer vaccines. We hypothesize that integrating deep, high quality, quantitative proteomic and,
especially, PTM-omic, HLA-peptidomic and metabolomic data with genomic and transcriptomic data will provide
novel insights into the pathophysiology of cancer and help to identify new, actionable targets for drug
development and treatment. Data will be rapidly distributed to the cancer biology and clinical communities, as
we have done for the past 15 years in the NCI-CPTAC program. The resulting datasets will enable a broad range
of investigation by many teams, accelerating molecularly-oriented cancer research toward biological and clinical
impact. We will also systematically develop and apply high sensitivity targeted MS assays to peptide/protein
targets identified in the Discovery Arm, with an emphasis on posttranslationally-modified peptides in signaling
cascades, oncogenic pathway regulators and effectors, and druggable proteins. Assays will use stable isotope-
labeled standards for unambiguous identification and quantification and follow Tier 2 guidelines developed from
the community-based effort led by the Broad proteomics team. Existing technologies will be further developed
and automated to enable comprehensive analysis of rare tumor cell populations, to evaluate tumor
heterogeneity, to increase depth and breadth of post-translational modification analysis, and to improve depth,
reliability and repeatability of peptide identification and quantification in general by intelligent data acquisition.

Public health relevance
Project Narrative Genetic alterations in human cancer have been systematically studied over the past decade, but the impact of a majority of these changes on the proteome – the functional end of the genome – are poorly understood. In this project we will use a state-of-the-art, unbiased analysis method, mass spectrometry-based proteomics, to define the protein content and identify key posttranslational modifications of the proteins that are involved in cell signaling. By integrating the proteomics data with the genomics and metabolomics data for the same samples/tumors we will shed new light on the biology of cancer and, importantly, we will help to identify new targets for therapeutic intervention.